The Neurobiology of Psychotherapy: Emotional Reactivity and Regulation in PTSD

Psychotherapy remains a cornerstone of treatment for many psychiatric disorders, and can be highly highly effective for a portion of patients. Very little, however, is understood about the neurobiological mechanisms of action of psychotherapy, nor are there biological markers for who is likely to respond. For some disorders, such as posttraumatic stress disorder (PTSD), psychotherapy is also the only evidence-based treatment, leaving non-responders with no effective treatment alternative. A lot is known, by contrast, about the neural basis of PTSD. Despite this, there is a large gap between our understanding of the neural basis of psychopathology in PTSD and the mechanisms of therapeutic change, and an even larger gap between those and an ability to use information from neuroimaging studies to guide the development of novel, neurocircuitry-targeting treatments. This latter issue is one, in fact, that plagues neuroimaging studies of psychiatric disorders more generally. Development of such novel treatments is a major goal of the Strategic Plan of the NIMH, and thus the BRAINS RFA, and may bring new hope to the treatment of severe illnesses, such as PTSD. The overall goal of this research program is to apply functional magnetic resonance imaging (fMRI) to elucidate the brain circuitry underlying improvement in response to psychotherapy, and to leverage this knowledge to develop a novel, personalized, neurocircuitrytargeting treatment using transcranial magnetic stimulation (TMS). One potential mechanism of action of psychotherapy is the alteration of patterns of dysfunctional emotional processing. Numerous studies with healthy subjects has delineated the neural circuitry for reacting to and regulating negative emotion, and how it is perturbed in psychopathology. We propose to build on this knowledge and study psychotherapeutic change and its pretreatment predictors by systematically probing emotional reactivity and regulation using fMRI in patients with PTSD before and after treatment with prolonged exposure psychotherapy (PE), versus wait list. Before receiving PE, all patients will undergo mapping of the prefrontal cortex using concurrent TMS and fMRI. Patterns of brain activation induced and modulated by TMS at a variety of prefrontal sites will be compared to those associated with successful PE, thereby forming the basis for a future neuroimaging-guided TMS intervention strategy that is directly informed by an understanding of the neurocircuitry of treatment response. A successful outcome in this study may therefore produce a paradigm shift in the translation of clinical neuroscience to brain circuitbased interventions.

Public health relevance
PROJECT NARRATIVE Psychotherapy is a commonly-used clinical tool in psychiatry and can be highly effective, but very little is currently known about either its mechanisms of action in the brain, or markers of who will or will not respond to psychotherapy. Moreover, for disorders such as posttraumatic stress disorder (PTSD), the only evidence-based effective treatment is psychotherapy, leaving therapy non-responders without an alternative effective treatment. The overall goal of this research program is therefore to use neuroimaging to elucidate changes in the brain circuitry underlying improvement with a specific form of psychotherapy for PTSD, and to leverage this knowledge to develop a novel, personalized, brain circuitry-guided treatment using non-invasive brain stimulation. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The overall goal of this research program is to apply functional magnetic resonance imaging (fMRI) to elucidate the brain circuitry underlying improvement in response to psychotherapy, and to leverage this knowledge to develop a novel, personalized, neurocircuitry-targeting treatment using transcranial magnetic stimulation (TMS). This ambitious goal is ideally suited for the BRAINS mechanism: a successful outcome will result in a solution to a key problem vexing many neuroimaging studies of psychopathology or treatment response - namely, that there is no route for translating knowledge of neural correlates into novel brain-based treatments, despite the significant public health implications of achieving this. Consider posttraumatic stress disorder (PTSD) - psychotherapy can be highly effective, but not all patients respond, and there is no effective treatment alternative for non-responders. Little is known about either the neural correlates of successful therapy, or of non-response. One potential mechanism of action is the alteration of patterns of dysfunctional emotional processing. Numerous studies with healthy subjects has delineated the neural circuitry for reacting to and regulating negative emotion, and how it is perturbed in psychopathology. We propose to build on this knowledge and study psychotherapeutic change by systematically probing emotional reactivity and regulation using fMRI in patients with PTSD before and after treatment with Prolonged Exposure (PE) versus wait list (WL). Before receiving PE, all patients will undergo mapping of the prefrontal cortex (PFC) using concurrent TMS and fMRI, in order to define patterns of brain activation induced and modulated by TMS at a variety of sites throughout the PFC. These patterns will be compared to those associated with successful PE, thus forming the basis for a future novel, personalized, neuroimaging-guided intervention strategy directly informed by an understanding of the neurocircuitry of treatment response. PTSD is a highly prevalent disorder with devastating consequences on daily life and function, and like other anxiety or mood disorders, is characterized by overwhelming and disruptive negative emotion. PE is associated with robust outcome, and can be consistently delivered to patients. Furthermore, interpretation of neural correlates will also be enhanced by data from animal models of fear and anxiety. As such, PTSD and PE are ideal venues for pursuing the goals of our research program. We will emphasize circuitry including the dorsal anterior cingulate and medial prefrontal cortex (ACC/mPFC) and amygdala, involved in reactivity, and the ventral ACC/mPFC and lateral PFC, involved in regulation. Within regulation, our particular focus will be the important contrast between implicit regulation, in which emotion is regulated spontaneously and outside of awareness, and explicit regulation in which emotion regulation requires conscious, deliberate effort. We believe that a study of the neural mechanisms of psychotherapy treatment response will result in major advances in: (1) design and application of novel psychotherapies, by identifying the mechanisms of action of therapeutic change, (2) identifying who is likely to respond to therapy, and who may instead benefit from an alternative, novel, treatment, and (3) forming a "neural template" upon which to base a novel intervention guided by neuroimaging. Our proposal will make major inroads into all three of these domains, as outlined below. Aim 1: Examine the effects of PE on emotional reactivity, and implicit and explicit emotion regulation. We hypothesize that after PE, but not after WL, patients will show: (a) greater reactivity to fearful face threat stimuli, as demonstrated by increased amygdalar and dorsal ACC/mPFC activation, (b) greater implicit regulation using a task in which subjects adapt to emotional conflict from trial-to-trial, as demonstrated by increased ventral ACC/mPFC activation and greater negative connectivity with the amygdala, and (c) greater explicit regulation during a picture-based reappraisal task, as demonstrated by increased medial and lateral PFC activation and greater amygdalar downregulation. Aim 2: We will examine the relationship between emotional reactivity, and implicit and explicit regulation at pretreatment and clinical outcome at 1-month follow-up to identify neural predictors of response. We hypothesize that greater clinical improvement will be predicted by: (a) greater reactivity, as demonstrated by greater amygdalar and dorsal ACC/mPFC activation to fearful faces, (b) greater implicit regulation, as demonstrated by greater ventral ACC/mPFC activation and greater negative connectivity with the amygdala during emotional conflict adaptation, and (c) greater explicit regulation, as demonstrated by greater ACC/mPFC activation during reappraisal. Aim 3: We will systematically map the PFC of all patients with TMS/fMRI prior to PE, by stimulating and briefly inducing plasticity at defined locations, and examine resultant brain systems-level activation changes. We hypothesize that individualized stimulation in the anterior lateral PFC or dorsal mPFC will modulate activation in dorsal and ventral ACC/mPFC regions important in successful treatment with PE, while stimulation in the inferior frontal gyrus or dorsal mPFC will modulate activity in the amygdala.